CELL - AND CIRCUIT - SPECIFIC EXPLORATION OF HIV NEUROGENOMICS IN CONTEXT OF OPIATE AND COCAINE ABUSE

HIV-associated neurocognitive disorders (HAND) persist in the era of combination antiretroviral therapy
(cART). Proof of HIV latency in human CNS is currently lacking, despite continued high prevalence of HIV-
associated neurologic disease and increasing recognition of CNS viral escape in people stably suppressed
with cART. One of the major issues regarding CNS HIV in need for study is HIV integration. With other words,
whether CNS HIV integration has biologically significant impact, contributing to pathogenesis? Issues of CNS
functional deficit are further complicated by the co-registered epidemic of opiate and other substance use
disorders (SUD) in people living with HIV/AIDS (PLWHA), as SUD also have profound impact on CNS function,
and potentially on HIV latency. Nowhere in the CNS is this more evident than in the neuroanatomic overlap of
HIV and SUD in striatonigral dopaminergic circuitry and frontostriatal projections, sites of predilection for
functional and neurobiologic disease as well as for increased burden of HIV infection. Accordingly, directly
utilizing brain tissues in these regions, from neurologically well-characterized HIV-infected individuals with and
without SUD, the goal of this application will be: (i) to replicate for brain some of the emerging genomic
mechanisms recently discovered in peripheral cells, linking HIV host genome integration and virus latency to
nuclear topography and open chromatin; (ii) to explore whether HIV signatures in transcriptomes and
epigenomes in dopaminergic circuitry is associated with prospectively monitored neurological status in the
years before death and exposure to drug of abuse; (iii) explore HIV expression and integration in potential
reservoir cells of the brain, including microglia and astrocytes derived from HIV+ brain at autopsy and (iv)
explore the impact of substance history on HIV integration and activity in primary microglial cultures derived
from HIV- brains at autopsy and (vi) expose primary microglia in culture to drugs of abuse and HIV. The
innovative experiments proposed here are expected to offer novel insights into epigenomic landscapes in
specific brain cells and explore potential links between neurogenomic status of the infected brain and
neurological and cognitive symptoms and substance abuse. While recognizing the high-risk aspects, these
analyses will nevertheless have predictable, high gain benefits in understanding the complex neurobiology
underlying HIV-associated CNS disease in PLWHA and SUD.

Public health relevance
Little is known how HIV affects the brain in the era of combination antiretroviral therapy, and how drug abuse, including cocaine and opiates, could be detrimental to the HIV infected brain. Our project, using human tissues from the Manhattan HIV Brain Bank, will explore genome organization and function in specific brain cells and neural circuits of the HIV infected brain in the context of opiate or cocaine abuse.